Education and Community Engagement Core (Core B)

ABSTRACT – CORE B
The goal of the Educational Outreach Core (Core B) in our UCSF Stanford Endometriosis Center for Discovery,
Innovation, Training and Community Engagement (ENACT) proposal is to promote awareness of endometriosis
and the implications of ENACT research activities to health care providers and the general public, and to create
a pipeline of future clinicians and investigators in endometriosis clinical care and research. To encourage
community involvement in ENACT activities and endometriosis literacy among all stakeholders, we will highlight
ENACT research in a variety of UCSF and Stanford-affiliated local and national community festivals,
conferences, webinars, and clinical trainee curriculums and create an annual ENACT Endometriosis Research
and Community Day Conference. Additionally, we will continue to promote training of researchers on
endometriosis by incorporating our ENACT research projects into our established structured educational
outreach and mentoring programs: the Science and Educational Partnership (SEP; high school interns), our
UCSF departmental Undergraduate Research Internship (URI; undergraduate interns), the San Francisco State-
UCSF NIH BUILD Program (Building Infrastructure Leading to Diversity; undergraduate interns), and the UCSF
AI4ALL high school initiative. Through these programs, we will continue to provide an innovative, formal,
intensive summer research and didactic experience that educates and trains students in various aspects of
endometriosis research. A specific focus of our outreach core will be understanding the needs of various
stakeholders and promoting the inclusion of diverse and underrepresented communities in our research projects,
training programs, and dissemination of ENACT project findings. As such, partnering with our UCSF Center of
Excellence in Women's Health and Black Women's Health and Livelihood Initiative, we will create a cross-
disciplinary advisory board and use their input and the results of an advisory board informed questionnaire to
understand the needs of the endometriosis community and advocates to inform our above efforts. All projects
and cores will participate in all Core B activities. Coordination of these teaching and community outreach
programs will provide a rich cross-generational, cross-disciplinary, and cross-educational experience, will
highlight our passion for basic and translational endometriosis research, and will engage the community to
participate directly in ENACT Center activities.